Dynamic prediction of type 1 diabetes risk and autoantibody status by a joint model of longitudinal and multistate models

Project Summary/Abstract
Type 1 diabetes is a chronic autoimmune disease that features the destruction of pancreatic beta-cells
resulting in insulin deﬁciency and daily insulin injections for survival. Early identiﬁcation of type 1 diabetes can
be achieved by continuously monitoring islet autoantibody status and longitudinal markers that measure the
immunological and metabolic functions. The goal of this proposal is to develop a statistical model that can
give dynamic predictions about type 1 diabetes risk based on autoantibody status and the historical data of an
individual. A longitudinal model for characterizing time-varying risk factors, a multistate model for predicting
autoantibody status, and a survival model for predicting disease progression will be combined in a joint model
to achieve the goal. The model will be applied to a dataset derived from The Environmental Determinants of
Diabetes in the Young (TEDDY) study. It may be challenging to develop a model with such a complex structure.
However, the advances in statistical methodology and computational technology have opened up opportunities
to resolve the problems. In Aim 1, we will formulate the proposed joint model and apply it to the TEDDY data.
Statistical inferences can be made to investigate how the changes in diabetes-related antoantibodies and other
longitudinal risk factors are associated with the risk for type 1 diabetes diagnosis. In Aim 2, based on the
proposed joint model, a dynamic prediction algorithm will be derived that predicts autoantibody development
and the subsequent risk of type 1 diabetes given the historical data of an individual. Lastly, in Aim 3, we will
evaluate the accuracy of the proposed dynamic prediction algorithm using a variety of diagnostic measures.
We expect that the proposed joint model will demonstrate better performance than the conventional static
survival models that use baseline characteristics or last available measurements. The proposed research can
answer critical research questions about the natural history of type 1 diabetes and the relationship between
longitudinal risk factors.

Public health relevance
Project Narrative A joint model of longitudinal and multistate models is proposed to investigate the relationship between the risk of autoantibody development and subsequent type 1 diabetes risk, and the longitudinal pattern of risk factors. Based on the joint model, we will develop a dynamic prediction algorithm that can predict type 1 diabetes risk given the status of autoantibodies and the historical data from an individual. This project can facilitate the early identiﬁcation of individuals at high risk of type 1 diabetes.